NCI SURVEILLANCE RESEARCH PROGRAM (SRP) SUPPORT

THE DIVISION OF CANCER CONTROL AND POPULATION SCIENCES (DCCPS), SURVEILLANCE RESEARCH PROGRAM (SRP) REQUIRES 1) AGGREGATED COUNTY LEVEL MULTIPLE-RACE DATA